Vascular Dysfunction and Inflammation

Nitric oxide. Our work has focused on cGMP-independent, non-canonical NO signaling and inflammatory gene regulation. NO up-regulated TNFa production (J Immunol 1994; Blood 1997) through a cGMP-independent signaling pathway (J Biol Chem 1997) that utilized NO-responsive Sp1 promoter binding sites (J Biol Chem 1999; J Biol Chem 2003). Dysfunctional eNOS upregulated TNFa (J Biol Chem 2000) through ROS and ERK1/2 (Am J Physiol 2001). NO activation of p38 MAPK stabilized IL-8 mRNA (J Infect Dis 1998; J Leuk Biol 2004). NO has diverse effects on transcript stability and translation (Nucleic Acids Research 2006; J Leuk Biol 2008). Sickle cell disease caused oxidant and inflammatory stress in the vasculature (Blood, 2004). This circulatory stress altered gene expression and arginine metabolism (Circulation, 2007). Anti-proliferative effects of NO were linked to p38 MAPK activation and p21 mRNA stabilization (BMC Genomics 2005; J Biol Chem 2006). Both NO and peroxisome proliferator-activated receptors (PPARs) protect the endothelium and regulate its function. PPARg was activated by NO through a p38 MAPK signaling pathway (FASEB J 2007). In contrast to the pro-inflammatory effects of high output NO, CO blocked proximal events in NF-kB signal transduction and broadly suppressed inflammation (PLoS One 2009). Nuclear receptors (NRs). In addition to inducing anti-inflammatory mediators, the glucocorticoid receptor (GR) suppresses inflammatory responses by tethering to DNA-bound NF-kB and AP-1 complexes that broadly control the expression of cytokines, chemokines and adhesion molecules. Effects on inflammation of other NRs including PPARg, MR, AR, and COUP-TF are being investigated in human endothelial cells (ECs). Rosiglitazone (RGZ) is a PPARg ligand/agonist used to treat type 2 diabetes. G-protein coupled receptor 40 (GPR40)/p38 MAPK/PGC1a/EP300 activation by RGZ was shown in human ECs to augment RGZ/PPARg genomic signaling (J Biol Chem 2015). Cognate GPR and nuclear receptor signaling networks may explain differences in the safety and efficacy of nuclear receptor targeted drugs (Pharm Research 2016). In human ECs, MR agonists repressed NF-kB mediated gene transcription, but trans-activated inflammatory AP-1 signaling in a DNA sequence, MR conformation, and AP-1 family member dependent fashion (J Biol Chem 2016). Aldosterone/MR activation of AP-1 may contribute to harmful inflammatory effects in CHF and PAH. Long-chain monounsaturated fatty acids (LCMUFA; i.e., C20:1 and C22:1) benefits were associated with the activation of PPAR signaling pathways, possibly via the activation of GPR40, and favorable alterations in the proteome of lipoproteins (Atheroscelerosis 2017). SPL, but not eplerenone was found to suppress both NF-kB and AP-1 inflammatory signaling independent of MR through the proteasomal degradation of XPB, a core subunit of the eukaryotic basal transcription TFIIH complex (Cardiovasc Res 2018). Loss of COUPTF2 (NR2F2) de-repressed JAK/STAT/interferon inflammatory responses in endothelial cells (ATS 2011; Aspen Lung Conference 2019; manuscript in preparation 2019). Selective AR modulators (SARMs) supplied by GSK were investigated and compared to dihydrotestosterone (DHT) to identify AR ligands with reduced pro-inflammatory potential and possibly net anti-inflammatory effects in the human vasculature. (in preparation). Pulmonary arterial hypertension (PAH). Two PAH clinical protocols, including a pilot study of spironolactone therapy (Trials 2013) and a natural history study investigating circulating markers of vascular inflammation and high-resolution cardiac magnetic resonance imaging (MRI), provide a source of patient specimens to support ongoing laboratory studies. Circulating ECs were identified by flow cytometry and their endothelial phenotype was validated using ultramicro analytical immunochemistry (Thrombosis and Haemostasis 2014). A meta-analysis of peripheral blood mononuclear cell (PBMC) expression profiling studies in PAH patients from multiple centers and across various expression profiling platforms (ATS abstract 2016) identified 1,269 differentially expressed, unique gene transcripts (FDR 1% and I2<40%). Interferon, mTOR/p70S6K, stress kinase and toll-like receptor signaling were enriched mechanisms associated with PAH pathogenesis (manuscript submitted). ECs with heterogeneous PAH-associated molecular defects including BMPR2, CAV1 and SMAD9, PHD2 (prolyl hydroxylase domain protein 2; EGLN1), COUPTF2 (NR2F2), and G6PC3 (glucose-6-phosphatase catalytic subunit 3) are being studied in vitro to create a comprehensive picture of pathogenic mechanisms and therapeutic targets. Loss-of-function mutations in bone morphogenetic protein type II receptor (BMPR2) are the most common genetic cause of PAH. BMPR2 knockdown (KD) in human pulmonary artery ECs (PAECs) activated Ras/Raf/ERK signaling, an oncogenic pathway, leading to proliferation, invasiveness and cytoskeletal abnormalities (Am J Physiol Lung Cell Mol Physiol 2016). Caveolin-1 (CAV1) loss-of-function (LOF), similar to BMPR2, produced a proliferative, hyper-migratory and inflammatory PAEC phenotype (Grover Conference 2015; ATS 2017) with activation of JAK/STAT/interferon signaling and AKT (Aspen Lung Conference 2019). Dermal fibroblasts from PAH patients with CAV1 mutations displayed this same abnormal cellular phenotype (ATS 2017; manuscript in preparation). SMAD9 LOF in human PAECs also produced an abnormal cellular phenotype characterized by proliferation, hypermigration, cytoskeletal and mitochondrial alterations and endothelial to mesenchymal transition, as well as non-canonical activation of AKT, ERK and p38 (ATS 2018; manuscript in preparation). Loss-of-function mutations in COUPTF2 (NR2F2) have been associated with congenital heart disease (CHD), a known cause of associated PAH. However, the molecular functions of COUPTF2 in vascular endothelium and its role in pulmonary vascular remodeling are incompletely understood. COUPTF2 silencing in ECs produced an interferon inflammatory response and exhibited a hyper-proliferative, apoptosis-resistant, and invasive phenotype that was associated with AKT activation and inhibition of Forkhead box protein O1 (FOXO1). Dickkopf-1 (DKK1), an upstream regulator of AKT, was increased in COUPTF2- and BMPR2-silenced PAEC supernatant. DKK1 knockdown abrogated the abnormal signaling associated with COUPTF2 LOF. Genetic defects associated with CHD may cause endothelial dysfunction that contributes to the flow-associated development of PAH (Aspen Lung Conference 2019: manuscript in preparation). An in vitro pseudohypoxia model of PAH was established by silencing PHD2 (prolyl hydroxylase domain protein 2; EGLN1) in LMVECs. PHD2-silencing stabilized HIF2alpha, decreased ASK-interacting protein 1 (AIP; DAB2IP), and activated AKT and ERK, while inactivating JNK, driving a proliferative and apoptosis resistant cellular phenotype. Markedly decreased lung tissue levels of PHD2 and AIP1 were found in our sugen/hypoxia rat model of PAH. (Aspen Lung Conference 2019; manuscript in preparation). Marked resistance to apoptosis has been a consistent feature of our endothelial cell models of PAH. Using the BMPR2 loss-of-function model as a prototype, apoptosis resistance was linked to vasohibin 1 (VASH1) and DLL4 loss, PI3K/AKT and ERK activation, and JNK suppression, (manuscript in preparation). Inhibiting PI3K/AKT restored apoptosis sensitivity in the three model systems tested to date, BMPR2, CAV1 and PHD2.